Vascular smooth muscle cell heterogeneity and disease

Project Summary
Vascular cell heterogeneity is a fascinating but poorly understood phenomenon. Numerous vascular cell
types undergo fate transitions under pathological conditions. This includes endothelial cells (ECs) undergoing
endothelial-to-mesenchymal transition (EndMT) and acquiring certain characteristics typical of macrophages
and smooth muscle cells (SMCs). SMCs, in turn, can also acquire macrophage-like features while bone
marrow-derived mononuclear cells can express certain EC and SMC markers when present at sites of chronic
inflammation. These cells fate transitions have been linked to various pathologies including atherosclerosis,
aneurysms, pulmonary hypertension and cavernous cerebral malformations. While the existence of these cell
fate transitions is now well accepted, little is known about the origin and characteristics of SMCs undergoing
these fate changes. Our preliminary data suggest that certain subpopulations of normal SMCs are particularly
prone to phenotypic modulation and are predominately pathogenic. We hypothesize that a small subpopulation
of normal SMCs is responsible for pathogenesis of CV diseases associated with expansion of the SMC pool
and that targeting these cells might prove to be a better and more specific therapeutic approach. It is our goal
in this application to define these cell populations, determine what drives their pathogenic responses and begin
identifying therapeutic approaches to controlling CV illnesses driven by specifically targeting these SMC
subsets.

Public health relevance
Project Narrative We propose to investigate the presence of a disease-prone population of smooth muscle cells in normal blood vessels and the contribution this population(s) make to cardiovascular illness characterized by smooth muscle proliferation. We postulate that many of these diseases are caused by expansion of the disease-prone cell pool. Proof of this hypothesis will open new therapeutic possibilities for treating thoracic and abdominal aortic aneurysms and potentially heart attacks, stroke and peripheral vascular disease.